Enhancer-Mediated BDNF Regulation

ABSTRACT:
Brain Derived Neurotrophic Factor (BDNF) plays essential roles in neuronal survival, differentiation, and
plasticity, and it contributes to learning and memory. The expression of BDNF is highly induced by neuronal
activity, allowing it to function in temporal coordination with the reception of sensory stimuli. Proper control of
Bdnf expression is essential to its function, because expressing too little or too much BDNF at the wrong times
or in the wrong places has been shown to impair brain development, plasticity, and function. Neuronal activity-
dependent induction of BDNF expression is mediated primarily at the transcriptional level, via the regulation of
stimulus-modulated transcription factors. Although prior studies sought evidence for mechanisms of Bdnf
regulation at this gene’s promoters, recent evidence shows increased long-range chromatin interactions with
Bdnf upon neuronal activation, which suggests the potential importance of transcriptional regulation at distal
activity-regulated enhancers. Using previously published ChIP-seq datasets and the chromatin conformation
data from these recent studies, I have identified six putative distal enhancer regions. Given the function of
enhancers in conferring specificity upon the regulation of gene transcription, I hypothesize that these enhancers
contribute to the stimulus-specific control of Bdnf transcription. In Aim 1, I will test the function and neuronal
activity-dependent regulation of these distal enhancers in mouse cortical neurons both using reporter assays
and in their endogenous chromatin context by activating or repressing the enhancers with dCas9-fusion proteins.
In Aim 2, I will focus on an intragenic enhancer of BDNF to test the hypothesis that the binding of the transcription
factor NPAS4 to this enhancer mediates a cell-type specific mechanism of regulation in the hippocampus in the
context of fear in vivo. This aim will take advantage of transgenic dCas9/CRISPR mice that I will use for enhancer
regulation in the context of neural circuits in vivo. Completion of these two aims will elucidate the specificity
provided by enhancers in Bdnf regulation. This proposal will also highlight the significance of transcriptional
regulatory mechanisms in coupling upstream stimuli to its appropriate downstream response.

Public health relevance
PROJECT NARRATIVE: Brain Derived Neurotrophic Factor (BDNF) is a growth factor that is essential for neuronal survival, differentiation, development, and plasticity. Transcriptional regulatory mechanisms provide the specificity required for the appropriate upregulation of BDNF in response to a wide variety of conditions and stimuli, which thereby allows for proper neuronal functioning. This proposal aims to identify and determine the specificity provided by enhancers, non-coding regulatory regions of the genome, in Bdnf regulation and as such will increase our understanding of the fundamental mechanisms that link BDNF’s expression and functions to sensory stimuli.